Interplay between brain oxytocin and CRF systems in stress-related visceral analgesia vs hyperalgesia: implications in IBS

PROJECT ABSTRACT
Irritable bowel syndrome (IBS), the main bowel disorder of the gut-brain interaction (DGBI), affects up to 10% of
the US population and is characterized by chronic abdominal pain and altered bowel habits. Early life adversity
(ELA) is recognized as a major predisposing factor for the development of IBS later in life. Despite years of
research, abdominal pain, the most important determinant of IBS severity, quality of life impairment and
healthcare utilization, remains a significant challenge in IBS management and an unmet need in patients.
Mounting evidence indicates that IBS patients have compromised engagement of the inhibitory descending pain
modulation systems, and contrary to healthy subjects, do not respond with a decreased visceral pain to rectal
distention under conditions of heterotypic stimulus. Using a novel non-invasive method of visceral pain
monitoring, we discovered that rats exposed to an acute or repeated water avoidance stress (rWAS), a
psychological stressor, display a stress-induced visceral analgesia (SIVA). Acute WAS-induced SIVA in naïve
male rats can be reproduced by low dose central injections of CRF, supporting a role for brain CRF signaling in
SIVA. In addition, we established that rWAS-induced SIVA is partly opiate-dependent in female and opiate-
independent in male rats. In preliminary data, we show that SIVA induced by acute WAS or icv CRF depends
on the central oxytocin (OT) system, which also exerts an inhibitory tone on basal visceral pain in male rats. We
further show that both male and female adult rats exposed to ELA in the form of limited bedding stress (LBS) as
neonates lose their ability to mount a SIVA in response to rWAS, and males, but not females, develop a delayed
stress-induced visceral hyperalgesia (SIVH). Based on existing and our novel findings, we propose that the loss
of SIVA and resulting SIVH to rWAS with prior exposure to ELA is linked to a dysregulation of brain oxytocinergic
pathways. The hypothesis will be tested in three aims: Aim 1 will establish that both brain CRF and OT signaling
contribute to visceral analgesia and interact throughout the pain modulating pathways to produce SIVA in a sex-
dependent manner. In Aim 2, we will establish the dysfunction of central OT following ELA, and investigate
whether alterations occurring at the functional (OT release, OT receptor expression, oxytocinase, epigenetic
alterations) underlie the loss of SIVA and development of hyperalgesia in adult rats exposed to limited bedding
stress (LBS) as neonates. In Aim 3, we will test whether the ELA-induced central oxytocin dysfunction can be
corrected using brain- or microbiota-targeted approaches. We will use integrative approaches including
molecular, pharmacological, bioassay, immunohistochemistry, in vivo functional assays and state of the art
techniques such as RNAscope-ISH-IHC combined analysis. Studying how alterations in the interaction between
the central oxytocin and CRF systems participate in the expression of stress-related visceral analgesia or loss
thereof could help explain the different degrees of visceral hypersensitivity in IBS and inform the development of
safer and more effective treatments for abdominal pain in stress-sensitive IBS.

Public health relevance
PROJECT NARRATIVE The perception of a visceral sensory input as painful or not depends on a dynamic balance between facilitatory and inhibitory modulating pain pathways and their integration at the supraspinal and spinal levels. Stress can influence this process and either exacerbate the sensory input leading to stress-induced visceral hyperalgesia (SIVH) or reduce it thereby promoting the recently described stress-induced visceral analgesia (SIVA). In this project, we aim to 1) define the role of central CRF and oxytocin and their interplay in SIVA, 2) unravel how early life adversity contributes to the dysregulation of the brain oxytocinergic signaling involved in the descending modulation of pain and reduction of the central stress response contributing to a loss of SIVA and a switch to SIVH in a sex-dependent manner and lastly, 3) evaluate the potential of brain- and gut-targeted oxytocin- modulating therapies to reverse these effects, opening new therapeutic venues to effectively treat visceral pain in irritable bowel syndrome.